Sexual Dimorphism in repair and regeneration after radiation exposure

ABSTRACT
This proposal aims to investigate the impact of sex as a biological variable (SABV) in the pathophysiology,
biodosimetry, and treatment of radiation injury. Current research lacks exploration of sex differences, including
the influence of gonadal hormones and sex chromosomes in hematopoietic (H-) and gastrointestinal (GI-) acute
radiation syndromes (ARS) and its long-term effects (DEARE). The study highlights the importance of
understanding these factors for gender-equitable medicine in radiation medical countermeasures. Initial data
shows increased male mortality in response to radiation, and metabolomic differences based on SABV. The
alarmin IL-33 has been shown in preliminary data and literature to exhibit sex-specific pleiotropic activation after
injury. To discern the roles of hormones and sex chromosomes, a four core genotypes (FCG) mouse model is
proposed, involving the deletion and relocation of the Sry gene. We hypothesize that SABV contributes to
radiation damage response and regeneration and sexual dimorphism in IL-33-mediated immune responses in
bone marrow and GI injury. This study will evaluate survival, histology, metabolomics, and transcriptomics in
male and female wild type mice, gonadectomized mice, FCG mice, and IL-33 modulated mice. This research will
provide insights into SABV in H-ARS and GI-ARS pathophysiology and inform potential novel therapies.

Public health relevance
NARRATIVE Sex can be a compounding factor in affecting the outcome of a variety of diseases. To date, the mechanisms of sexual differences in radiation sickness have not been fully investigated. In this project, we will gain key insights into sex differences between males and females from the contribution of gonadal hormones and sex chromosomes following exposure to ionizing radiation. Such findings will be invaluable in the case of a nuclear catastrophe, where an exposed population will need to be triaged based on their risk for radiation syndrome severity. This study will also evaluate gonadal sex hormones and IL-33 as potentiators of radiation-induced disease, allowing for the potential identification of novel targets of therapeutic strategy for individuals suffering from radiation-induced disease in the short and long term.